Research Education Component

PROJECT SUMMARY/ABSTRACT (REC)
The UTMB OAIC will continue to promote the development of the next generation of research leaders in
geriatrics and gerontology through direct financial support for salary, structured mentoring, participation in
interdisciplinary conferences, didactic training, and networking activities. Scholars will have access to
infrastructure support from the Research Education Component (REC), other OAIC cores, the Institute for
Translational Sciences (CTSA), and other OAICs as appropriate. The specific aims of the REC are to: (1)
Work with UTMB and its partner institutions to identify, recruit, and retain a pool of scholars with the potential
for successful careers in aging and disparities research; (2) Use an innovative “Precision Faculty
Development” model to create a career and professional development program customized to each REC
Scholar; and (3) Foster a community of REC scholars to promote interdisciplinary collaborations, peer-to-peer
support, and professional development for a successful career in aging research. These aims will allow us to
build on our success. To date, the UTMB OAIC has trained 41 scholars, 55% clinicians, with 85% of REC
Scholars securing external funding on their path to becoming independent investigators. Our OAIC theme for
the 2020-2025 cycle is: Enhance functional independence in older adults with chronic disabling
conditions by reducing health disparities. This theme guides a career development program in which earlycareer
faculty acquire capabilities in scholarly communication, scientific leadership, and translating research
findings into effective interventions, with an emphasis on health disparities. The aims will be achieved by
integrating the REC Scholars with teams conducting research relevant to the OAIC goal of identifying
pathways of physical function and developing interventions that improve functional recovery and enhance
independence in older adults. These teams will be multidisciplinary and led by experienced mentors with
demonstrated research expertise and documented external funding. The REC leadership and mentors include
senior faculty with both research and administrative experience related to career development, such as
directors of training programs, T32s, and K12s. Additionally, the REC includes clinician-scientists as members
of each research team to ensure that the mentoring experiences are high quality and include appropriate
translational opportunities related to disparities, aging, and geriatrics research.